Administrative Core

PROJECT SUMMARY - ADMINISTRATIVE CORE
The overall objective of the Administrative Core of the Environmental Health Sciences Research Center
(EHSRC) is to coordinate, integrate and assess the Center’s cores, facilities, membership, activities, and budgets
in support of its vision and aims. The Administrative Core is guided by the Executive Committee, the Internal
Advisory Committee (IAC), and the External Advisory Committee (EAC), with the IAC serving as the primary
governing body of the Center. The EAC, which is convened annually, provides guidance in meeting the NIEHS
Strategic Goals. The specific aims of the Administrative Core are to: Aim 1) Promote the vision, goals and aims
of the Center; Aim 2) coordinate day-to-day Center activities, including membership, budgets, reporting
functions, and organize meetings of the Thematic Areas, IAC and EAC; Aim 3) assess and document the
productivity and effectiveness of scientific and programmatic activities; Aim 4) provide interdisciplinary
coordination and foster interactions between Center members, Thematic Areas, and Facility Cores, and facilitate
research translation from “data to knowledge to action”; Aim 5) administer and ensure the success of the Pilot
Grant Program (PGP) and Career Enhancement Program (CEP); Aim 6) promote environmental health
engagement and translational research through the Community Engagement Core (CEC) and the Integrated
Health Sciences Facility (IHSFC); Aim 7) foster interactions with NIEHS, Environmental Health Sciences (EHS)
Core Centers elsewhere and with other EHS organizations; and Aim 8) leverage institutional resources for the
Center. To attain these Aims, the Administrative Core provides a centralized organizational base to the
programs, research, facilities, translational, and community engagement activities of Center members. The
Administrative Core maintains the Center’s finances and accounts, manages reporting and compliance,
facilitates regular meetings of the Thematic Areas and the Center’s governing committees, administers the PGP
and CEP, and promotes activities within the CEP and the Center’s Thematic Areas and Facility cores. It
documents the productivity and effectiveness of EHSRC components by tracking, for example, publications,
facility services provided to Center investigators, pilot grant awards, grant progeny emanating from pilot grants,
Associate Members mentored to Member status, the impact and effectiveness of CEC programs, and
effectiveness of research translation activities. The Administrative Core works with the CEC and the IHSFC to
translate environmental health research to the Center’s audiences. The Center Director engages with collegiate
deans and central administrative officials of the University to leverage institutional support for the EHSRC. This
Core will continue to serve EHSRC needs for an administrative body that facilitates opportunities for, and
interactions between, members, research projects, programmatic activities, and facilities, and ensures the
smooth operation of this complex, multidisciplinary Center.